Co-Regulation of Alternative Lengthening of Telomeres and Chromatin Dynamics in ATRX-DAXX deficient cancer cells

Abstract
Cancer cells must activate a telomere elongation mechanism and acquire genomic alterations. Many of the most
lethal cancers rely on the Alternative Lengthening of Telomeres (ALT) pathway. ALT is a specialized
homology directed repair (HDR) mechanism dedicated to repair and elongate telomeres, thereby ensuring the
proliferative immortality of these cancer cells. Recurrent inactivating missense mutations in genes encoding the
ATRX-DAXX chromatin remodeling/histone H3.3 deposition complex exhibit a strong concordance with
tumors in which ALT is activated, with both arising late in metastatic disease. These loss of function mutations
disrupt ATRX-DAXX mediated assembly of chromatin, provoking replicative stress and double-strand breaks
(DSBs) within telomeres that is believed to stimulate ALT-associated HDR. Whereas the HDR mechanisms that
underpin ALT have been extensively studied, the mechanisms governing how cells compensate for loss of
ATRX-DAXX to maintain chromatin while also acquiring metastatic traits remain ill-defined. This proposal
builds on our recent report that upon inactivation of ATRX-DAXX, a related chromatin assembly factor known
as HIRA becomes indispensable for de novo histone H3.3 deposition and telomere extension in ALT cancer
cells. Furthermore, we discovered that the depletion of HIRA provoked acute systemic death of ATRX-DAXX
deficient cells. Strikingly, this cytotoxicity was reversed by reconstitution of ALT cells with wild type ATRX
protein. These data provided compelling evidence for a compensatory function adopted by HIRA due to
ATRX-DAXX deficiency that could be harnessed to eliminate ALT cancer cells.

Public health relevance
PUBLIC HEALTH RELEVANCE: Telomeres are specialized structures located at the ends of chromosomes that fulfill an essential role in maintaining the structural and genetic integrity of the genome. Telomeres do this by controlling the number of times each cell can divide. Once a cell becomes damaged or acquires a potentially harmful mutation, telomeres signal to other proteins that elicit a permanent cessation of cell division. This prevents the development of cancer. However, mutations can bypass this arrest in cell division and re-initiate cellular division. These cells must also re-activate a mechanism that ensures that telomeres once again maintain the structural integrity of chromosomes but are no longer capable of blocking cell division. This is achieved by activating one of two different telomere maintenance mechanisms. One of these mechanisms is known as alternative lengthening of telomeres, or simply ALT. Cancers that rely on ALT tend to be among the most aggressive and patients often have a poor prognosis. Therefore, understanding the molecular basis for the activation and maintenance of the ALT pathway and identifying the key regulators of ALT is critically important for improving the detection and treatment of this devastating disease. We have identified an essential mediator of ALT telomere maintenance named HIRA. We show that deletion of HIRA or attenuating its function is capable of killing cancer cells that rely on ALT. Developing a greater understanding of the molecular function of HIRA and evaluating its potential as a cancer therapy target is the focus of our study.